Cancer Control Program (CC)

CANCER CONTROL PROGRAM
PROJECT SUMMARY/ABSTRACT
The scientific goals of the Chao Family Comprehensive Cancer Center (CFCCC) Cancer Control (CC) Program
are to foster and facilitate research that identifies and reduces cancer risk and improves cancer outcomes and
quality of life for patients and survivors in the CFCCC Catchment Area and beyond. The CC Program contributes
to the overall mission of the CFCCC by strengthening the knowledge base for developing, implementing,
evaluating, and disseminating strategies to our community to prevent and reduce cancer incidence, mortality,
and morbidity. CC members work closely with the Office of Community Outreach and Engagement (COE) and
provide leadership and guidance in conducting population-based studies and clinical trials. CC members play
an important role in translating discoveries to the population. The CC Program Specific Aims are to identify,
understand, and control risk factors to prevent cancer and improve outcomes through diagnosis, treatment and
interventions to improve survivorship. CC members conduct research that spans the cancer control continuum.
Researchers examine genomic and environmental influences on cancer; design, implement, and evaluate
clinical trials to increase cancer screening; develop and assess innovative approaches to improve quality of life
in children, adolescents, and young adults with cancer; test novel biobehavioral interventions in cancer survivors;
conduct clinical trials to improve outcomes and prevent recurrence; and work to reduce disparities that impact
those living within our community and beyond.
Membership: 45 Members from 19 Departments and 5 Schools
Funding: $1,528,757 NCI (Directs); $3,988,348 Other Peer-Reviewed (Directs)
Accruals: Interventional: 1,015; Treatment: 0; Institutional/Investigator-Initiated: 1,132
Publications: Total: 607; High Impact Journal: 84 (14%); Intra-programmatic: 68 (11%);
Inter-programmatic: 92 (15%); Inter-Institutional: 410 (68%)

Public health relevance
CANCER CONTROL PROGRAM PROJECT NARRATIVE Per PAR-20-043, a Project Narrative is not required for this component.